BLRD Research Career Scientist Award Application

The two primary goals of the principal investigator (PI)’s research are to lower the number of bone fractures
associated with diabetes, aging, osteoporosis, hypertension, cancer, and genetic diseases and to facilitate timely
healing when fractures do occur in patients with these co-morbidities. With respect to the first goal, the PI’s
FRACTURE CURB project endeavors to identify mechanisms by which hypertension favors poor fracture
resistance of bone. In doing so, aims of the project are (i) to determine whether sex steroids modulate the decline
in bone mass and quality associated with hypertension using gonadectomy models, (ii) to ascertain the cellular
source of colony stimulating factor (CSF) 1 in hypertension-induced bone loss using transgenic mouse models,
and (iii) to test whether inhibiting CSF1 slows hypertension-related bone loss in aged mice and improves bone
strength with respect to a standard osteoporosis treatment known as intermittent recombinant parathyroid
hormone 1-34 (PTH1-34). One preclinical model of hypertension involves continuously delivering vehicle or
angiotensin II for 6 weeks, to wild-type, adult mice or adult mice that lose Csf1 in cells of the osteoblast lineage
or endothelial cells upon the administration of tamoxifen. The other model of hypertension involves removing
one kidney and subcutaneously implanting a control pellet or deoxycorticosterone acetate (DOCA) salt pellet in
adult mice to stimulate aldosterone and then giving the mice 1% salt water to drink for 3 weeks. The analysis
techniques in all aims include: micro-computed tomography (μCT) evaluations to assess cortical structure,
trabecular architecture, and volumetric bone mineral density; mechanical testing of bones (femur and lumbar
vertebra) to assess fracture resistance of cortical and trabecular bone; serum markers of metabolism to
understand changes in bone remodeling; gene profiling (transcriptomics) using nanoString technology to identify
signaling pathways; histology of bone to further assess effects on bone resorption and formation; and flow
cytometry of immune cells from the bone marrow to identify mediators. From the application of these techniques
to mouse experiments, the PI will possibly identify a key driver of the hypertension-related decline in bone
strength. Inhibiting CSF1 along with enhancing bone anabolism with an anabolic therapy (intermittent PTH1-34)
could be identified as a potential treatment strategy in protecting bone health in hypertension. With respect to
the second goal, the Validation project endeavors to validate a preclinical model of polytrauma that causes
prolonged hyper-inflammation, impairments in musculoskeletal (MSK) tissue repair, and a decline in overall
wellness (e.g., osteoporosis, cognition, pain perception, and mobility). In doing so, aims of the project are to
determine whether (i) combining muscle injury and femur fracture with transdermal burn causes musculoskeletal
complications of repair, (ii) this polytraumatic injury model also causes a decline in the fracture resistance of
bone and in cognitive function, and (iii) the combined injuries cause prolonged hyper-inflammation. The validation
goal of the first aim is to determine if there is a delay in fracture healing (e.g., incomplete union at 21-days post-
injury) and impaired muscle regeneration (e.g., fibrosis and soft tissue mineralization at 42-days post-injury) as
the injuries become more severe. The validation goal of the second aim is to determine if the combined
polytrauma model causes deleterious changes in wellness, including bone fragility, impairment in memory,
hypersensitivity to pain, and reduced mobility compared to non-injury sham. The validation goal of the third aim
is to determine if the addition of burn to muscle injury and femur fracture prolongs the hyper-inflammatory
response and prolongs tissue inflammation compared to the lesser injured or uninjured mice. If successful, this
project will support the combination of skin burn, femur fracture, and muscle injury to assess prognostic indicators
and pharmacologic interventions aimed at improving the ability of Veterans to recover from polytraumatic injuries.

Public health relevance
The principal investigator (Pl) uses advanced techniques to assess the structural, compositional, and mechanical properties of bone across the multiple hierarchical levels of this tissue's organization. Combining these techniques with preclinical animal models of disease and gene function, this research investigates mechanisms underlying conditions and diseases that affect many Veterans. This includes how hypertension weakens bone and how severe injury delays fracture union, causes bone fragility, and favors soft tissue mineralization. Fragility fractures and the inability of musculoskeletal tissues to heal reduce the quality of life because they reduce the mobility of Veterans and cause pain. Thus, by successfully completing the Pl's ongoing research projects, new diagnostic procedures and therapeutic strategies for bone health will be developed in way that is translatable to the clinic. The Pl has already begun translating measurements of bound water and pore water from animal studies to human imaging and seeks to prevent fractures and promote their healing when they do occur. Project Narrative